Training Program in Mechanisms of Virus-Host Interactions

Summary:
The Mechanism of Virus-Host Interactions Training Grant is a multidisciplinary training program designed to
train and educate pre-doctoral and post-doctoral trainees in the broad discipline of Virology. This proposal
requests continued support for years 21-25 of the Virology Training Program. The faculty is derived from the
Icahn School of Medicine at Mount Sinai (ISMMS) with Dr. Tortorella as the Program Director and Dr. Peter
Palese as the Co-Program Director. The research training emphasis is directed toward teaching pre-doctoral
and post-doctoral trainees the theory and experimental approaches required for independent scientific
investigations. Trainees learn the molecular mechanisms involved in virus replication and host responses to
viral infections. Research training areas also include novel approaches for antiviral strategies and vaccine
development against medically relevant viruses. Our trainees are highly successful in attaining independent
research positions, peer-reviewed publications, and extramural research funding. Accordingly, four pre-
doctoral and three post-doctoral positions are requested. The specific aim of the program is to recruit and
provide rigorous training to high caliber students and fellows. The continued support of this program will aid
trainees in all phases of their development including understanding scientific method, interpretation of results,
presentation of data and conclusions, research ethics, and career guidance. By combining the strengths of an
outstanding group of virologists, we have created a world-class virology Training Program. This program is
built upon existing collaborations, including research grants, and joint publications between faculty members at
ISMMS. The program faculty consists of twenty outstanding virologists who use a diverse array of experimental
strategies to study the molecular, cellular, biochemical and immunological interactions of viruses with their
hosts.

Public health relevance
Narrative The Mechanisms of Virus-Host Interactions Training Grant is vital to the development of the next generation of virologists. The trainees will be leaders in the field of Virology developing strategies to prevent and limit virus pathogensis.